Neuropathology and Biochemistry Core

PROJECT SUMMARY – NEUROPATHOLOGY AND BIOCHEMISTRY CORE
Neuropathologic evaluation remains an important part of clinical and translational research on dementia with
Lewy bodies (DLB) and Parkinsonian disease dementia (PDD), disorders that have been grouped in the
research recommendations of NIH-sponsored Alzheimer Disease and Related Dementias (ADRD)
recommendations as the Lewy body dementias (LBD). The purpose of the Core B: Neuropathology is to
perform quantitative postmortem neuropathologic evaluations and data collection for all LBD brains that will be
distributed to the CWOW scientists. The Core B will provide pulverized frozen human brain samples, brain
homogenates, purified protein preparations (Aβ and α-Syn) or paraffin sections of LBD cases and matched
controls to all CWOW investigators, as well as to qualified investigators at other research institutions as
approved by the Executive Committee of Core A and the Mayo Clinic Biospecimen Committee. The
quantitative traits generated include counts of cortical Lewy bodies, semiquantitative estimates of substantia
nigra neuronal loss, dopaminergic deficiency in putamen with tyrosine hydroxylase immunohistochemistry and
counts of senile plaques and neurofibrillary tangles in cortical and subcortical areas with thioflavin S
fluorescent microscopy. Core B will perform digital microscopy and image analysis on sections processed for
immunohistochemistry for α-Syn, phospho-tau and Aβ40, Aβ42, as additional other quantitative
endophenotypes, such as phospho-TDP-43.